The OAI Collaborative Osteoarthritis Research Enterprise (OAI CORE) Knowledgebase

PROJECT SUMMARY
We propose to create a knowledgebase to extract, accumulate, organize, annotate, and link growing bodies of
information related to the Osteoarthritis Initiative (OAI), one of the most prolific osteoarthritis (OA) cohorts in
history. The OAI is a unique and rich 16-year multicenter observational study with comprehensive publicly
available clinical data, medical images, genetics, and biospecimens from 4,796 people with or at risk for
knee OA. Consequently, the OAI is a valued resource to a large and dynamic research community, with ~1,000
publications (>100/year for the past 6 years) and >770 researchers having multiple publications using OAI data.
Despite the OAI’s widespread adoption among OA researchers, it retains considerable untapped potential
to support investigations in wide-ranging OA-related fields. Utilization of OAI data, images, and
biospecimens would be enhanced by a centralized resource that leverages contemporary technology to
raise awareness in a broader research community and provide logistical support in leveraging the OAI,
ensuring that the OAI will be a durable resource. We propose to create a biomedical knowledgebase to
promote and facilitate the use of the OAI to accelerate discovery. We will use trustworthy governance and
good data practices to offer high-quality and efficient services to meet the community’s needs using an
intuitive and centralized resource. We will create two broad platforms with the first being the Online OAI
Resource Library, primarily a stand-alone online resource with 1) foundational documents (OAI Archive; e.g.,
approved consent forms), 2) presentations and educational opportunities (OAI.Edu), 3) annual State of the OAI
Reports, 4) an online calculator for descriptive analyses (OAI Explorer), 5) a database of available OAI
biospecimen, and 6) datasets that instructors can use in classes (OAI Learning Lab). Our second will be the OAI
Engagement Services, where the OAI CORE will directly engage with interested investigators to assist with an
array of activities, including 1) discussing available data and limitations, 2) creating parsimonious data or imaging
sets, 3) preparing new datasets to link to the publicly available data, and 4) connecting new OAI investigators
with experienced OAI investigators during one-on-one and group sessions – a catalyst to facilitate collaboration
and new research. We will also monitor and report >25 metrics of usage, utility, and scientific impact and
advancement of knowledge and understanding. This knowledgebase will promote and maintain the OAI, facilitate
high-quality studies of existing data, and encourage the generation and sharing of new data from the OAI among
OA researchers and the broader research community, accelerating the pace of discoveries.

Public health relevance
PROJECT NARRATIVE The Osteoarthritis Initiative (OAI) is one of the most productive osteoarthritis cohorts in history due to its rich publicly available resources (e.g., clinical data, medical images, biospecimens), but it is challenging to leverage the complex data. The use of OAI data, images, and biospecimens would be enhanced by a centralized resource that uses technology to raise awareness in a broad research community and provide support in leveraging the OAI, ensuring that the OAI will be a durable resource. The knowledgebase will offer an online resource library and engagement services to 1) promote the OAI, 2) facilitate high-quality studies, 3) foster collaborations, and 4) encourage the organizing, annotating, and linking of new data from the OAI among osteoarthritis researchers and the broader research community.